COVID-19 airway inflammation is due to Spike inhibition of CFTR signaling

Abstract
Over 860,000 COVID-19 deaths have occurred in the U.S., and more than 5.5 million deaths have
occurred world-wide. Consequently, development of effective antiviral drugs that block infectivity and airway
inflammation continue to be a global health priority. Inflammation in the COVID-19 airway is due to increased
NFκB and Epithelial Sodium channel (ENaC) signaling. Cystic fibrosis (CF), a genetic disease caused by
inactivating mutations in the CFTR gene, also has the same proinflammatory NFκB and ENaC signaling
phenotype in the airway. Using a differentiated human epithelial "lung-on-a-chip" platform, we find that ACE2,
the receptor protein for the SARS-CoV-2 Spike protein, co-immunoprecipitates with CFTR. Furthermore,
exposure of differentiated epithelia to the SARS-COV-2 Spike protein dose-dependently suppresses cyclic
AMP-dependent CFTR chloride channel activity and CFTR protein expression. Spike-dependent loss of CFTR
also activates TRADD-dependent NFκB signaling and proteolytically activates ENaC. We have also found that
Spike-dependent loss of CFTR may be due to failure of endosomal recycling to return apical CFTR to the
plasma membrane. Finally, we find that nanoMolar concentrations of cardiac glycoside drugs such as
ouabain, digitoxin and digoxin, which competitively inhibit Spike:ACE2 binding, rescue Spike-dependent
reduction in CFTR activities. We have therefore hypothesized that binding of SARS-CoV-2 Spike protein to
ACE2 in the lung causes loss of CFTR signaling and activation of proinflammatory NFκB and ENaC
signaling. To further test this hypothesis we propose the following Specific Aims: SA #1: To define the
mechanism by which SARS-CoV-2 Spike protein reduces CFTR channel activity and CFTR protein
levels. We will determine the mechanism by which ACE2 interacts with CFTR. We will determine the
mechanism by which Spike protein interaction with ACE2 leads to loss of CFTR. SA#2: To define the
mechanism by which SARS-CoV-2 Spike protein drives activation of ENaC and NFκB signaling. We will
determine the mechanism by which Spike-induced loss of CFTR protein results in activation of TRADD-
dependent NFκB ENaC signaling. SA#3: To identify protective mechanisms of cardiac glycosides on cell
and animal models of COVID-19 disease. We will test whether cardiac glycoside drugs block native SARS-
CoV-2 infection of epithelia and rescue hamster models of COVID-19. .
Novelty and Significance: To our knowledge this is the first time COVID-19 airway inflammation has been
traced to inhibition of CFTR signaling. Consistently, COVID-19 patients who are also CF carriers, with only one
wildtype CFTR gene and only 50% of CFTR function, were recently reported to suffer more severe COVID-19
symptoms and earlier death than normal subjects with COVID-19.

Public health relevance
Project Narrative Development of an effective antiviral drug for COVID-19 is widely considered to be a global health priority. COVID-19 severity and death is principally due to a proinflammatory cytokine storm in the lung, which is caused by CFTR loss and consequent activation of NFκB and ENaC signaling. Cardiac glycoside drugs such as ouabain and digitoxin potently block infection by inhibiting the viral spike from binding to ACE2. By inhibiting viral entry, the cardiac glycosides prevent loss of CFTR, and thereby also prevent activation of NFκB and ENaC signaling.